Metal-oxidative stress interplay in periodontopathogen Prevotella intermedia

Iron-oxygen interplay is essential in establishment of an infection that includes the ability of the pathogen to escape host response and multiply within its host. Although it differs significantly in anaerobes, that include periodontopathogens such as Porphyromonas gingivalis and Prevotella intermedia, when compared to aerobes little is known as regards the iron homeostasis in anaerobic bacteria. We have shown that many putative iron acquisition mechanisms are regulated by iron in both Porphyromonas gingivalis and Prevotella intermedia, however, our data also show that the orthologue of the ferric uptake regulator, Fur, is not the major iron homeostasis regulator in P. gingivalis pointing out that novel mechanism of iron regulation must be present in this bacterium. Furthermore, the P. gingivalis oxidative stress regulator, OxyR, is involved in hemin homeostasis in this bacterium. Based on such striking differences in iron-dependent regulation we hypothesize that the differences extend beyond the genus Porphyromonas and include other anaerobic bacteria belonging to the phylum Bacteroidetes. Here we propose to extend our investigations by characterizing the role of the P. intermedia orthologue of a ferric uptake regulator, Fur, in iron homeostasis in this bacterium. Furthermore, as iron plays crucial role in generation of oxidative stress species we will also examine the role of a P. intermedia homologue of the oxidative stress regulator, OxyR. First, we will define the biological role of the two regulators in P. intermedia using biological assays as well as genomic profiling of both gene and protein expression. Next, we will define the regulons of both Fur and OxyR in P. intermedia. As P. intermedia is anaerobic bacterium and is distantly related to the well known aerobic, alpha proteobacteria such as Escherichia coli, we hypothesize novel findings will be gained from this investigation. The results of our study will help to define iron and oxidative stress homeostasis mechanisms that in turn may serve as targets for the future design of antibacterial agents for P. intermedia. Since P. intermedia is phylogenetically similar to many other anaerobic medically significant bacteria such information will also be applied in development of an alternative methods of preventive measures for other bacteria.

Public health relevance
Significance The long-term objective of this application is to identify and characterize the regulatory mechanisms of anaerobic bacteria. Oral periodontal pathogens have to respond to constantly changing environmental conditions, however, so far the regulatory mechanisms governing the protein expression are poorly understood. Our work is expected to provide clues how the bacterium tolerates various environments and ultimately, we predict that this work will lead to identification of targets for the design of novel and specific therapeutic agents for treatment of periodontal diseases.